Endogenous barcoding to determine complex dynamics of adult neurogenesis in aging and Alzheimer's disease

1 ABSTRACT
2
3 The population of people living with HIV gradually ages, in part due to the efficiency of antiretroviral
4 therapy (ART) which has significantly improved the life expectancy of infected individuals. This aging population
5 inevitably faces an increased risk of developing neurodegenerative disorders including Alzheimer's disease (AD).
6 These concerns are
7 These deficits may be due solely to the HIV-1 infection;
8 however, this may also indicate that long-term ART itself contributes to the impairments. The latter possibility is
9 of particular concern given that a growing number of uninfected individuals employ use antiretrovirals (ARVs) as
10 pre-exposure prophylaxis (PrEP). The mechanisms underlying ART-induced changes and their impact on brain
11 circuitry that may be affected by prolonged treatment with ARVs are unclear; even less is known about the action
12 of ARVs in the aging and AD-afflicted brain. The mechanisms of ART-induced changes and the brain circuitry
13 that may be affected by prolonged treatment with ARVs are unclear; even less is known about the action of
14 ARVs in the aging and AD -afflicted brain.
15 We propose to apply our recently developed array of new tools for analyzing neurogenesis and for
16 constructing, comparing, and analyzing 3D whole-brain maps of neuronal activation in the mouse brain to reveal
17 the critical neural circuitry affected by representative ARVs. Our hypothesis is that 3D patterns of neuronal
18 activation in aging and AD model animals exposed to ARVs and involved in challenging behavioral tasks can
19 both reveal the crucial circuitry defining these effects and serve as unique signatures of the treatments’
20 effects. Furthermore, our recent results demonstrate that treatment with ARVs can affect adult hippocampal
21 neurogenesis, thus indicating another potential vulnerability of the ARV-exposed aging and AD brain. This
22 proposal is directly related to the parent R01 grant which also focuses on the aging and AD brain.
23 In specific aim 1, we will determine the effect of prolonged treatment with representative ARVs on stem
24 cells and adult-born neurons in the hippocampus of aging and AD model mice. In specific aim 2, we will
25 determine the critical shared components of neural circuitry affected by prolonged exposure to select ARVs. We
26 will generate mesoscopic global maps of neuronal activation in aging and AD model mice presented with relevant
27 cognitive challenges after exposure to ARVs. We will then subject the mapping datasets to our stepwise selection
28 pipeline to identify the critical brain regions and neural circuits altered by the treatments. Our experiments will
29 reveal the effect of ARVs on hippocampal neurogenesis and will create a circuitry map space for the action of
30 ARVs upon which other circuitry maps that describe various responses to treatments in the context of aging and
31 AD can be projected and compared.
32
further compounded by the prevalence of cognitive deficits observed in a substantial
proportion of HIV-1-infected individuals undergoing ART.

Public health relevance
NARRATIVE A large proportion of people who take antiretroviral drugs for a long time, whether to control the HIV-1 infection or as pre-exposure prophylaxis, experience problems with memory, executive control and other brain functions. There is a growing concern that drugs themselves may contribute to these impairments. Moreover, an increasing cohort of the people taking antiretrovirals is entering advanced age and some of them will inevitably develop age-related disorders such as Alzheimer's disease. We propose using new approaches that we developed, to determine the consequences of the long-term exposure to antiretroviral drugs in the animal models of aging and Alzheimer's disease.